Integrated single cell and spatial mapping of habenula circuitry to identify projection-specific molecular pathways associated with opioid exposure.

PROJECT SUMMARY
The national opioid epidemic is a significant public health crisis requiring accelerated efforts to translate
mechanistic studies into therapeutic developments. Substance use disorders (SUDs) feature dysregulation of
brain reward circuits, especially dopaminergic systems governing motivated behavior. The habenula (Hb) is a
key reward circuitry hub that sends direct projections to the ventral tegmental area (VTA), as well as other
aminergic centers, to modulate reward seeking. Hb circuit dysfunction is associated with addiction, but the
molecular mechanisms mediating this dysfunction, especially in the context of opioid use disorder (OUD) are
unknown. Here we propose to use integrated single cell and spatial transcriptomic approaches to map
molecular changes associated with chronic opioid self-administration in specific cell populations across the
rodent Hb (Aim 1). Using retrograde labeling and nuclear tagging, we will also generate transcriptomic
signatures for Hb neurons projecting to the VTA (Hb-VTA projections) and evaluate their susceptibility to
molecular changes associated with chronic opioid exposure (Aim 2). Finally, we will integrate these
complimentary rodent datasets with molecular data we are generating in the post-mortem human Hb in the
context of OUD as part of an ongoing NIDA-funded award (1R01DA55823) to identify specific Hb cell
populations and projection neurons enriched in genes associated with opioid addiction in the human brain (Aim
3). The proposed study will generate the first spatially-resolved atlas of opioid-induced gene expression
changes in the rodent Hb at cellular and circuit resolution. Integration of this molecular map with clinical gene
sets in the context of OUD will help translate insights from rodent models into cell type- and circuit-based
therapeutic approaches for the treatment of addiction.

Public health relevance
PROJECT NARRATIVE Dysregulation of the habenula, a key node of reward circuitry governing motivated behavior, is associated with addiction, but the molecular mechanisms mediating its role in substance use disorders are largely unknown. In this application, we will use single cell and spatial transcriptomic approaches to identify molecular changes associated with chronic opioid self-administration in cell types and projection neurons of the rodent habenula. Upon integration with human habenula data in the context of opioid use disorder, our study will help prioritize molecular pathways that can be targeted to advance cell type and circuit-specific therapeutics for the treatment of opioid addiction.